Digital Technology Core

Project Summary: Digital Technology Core
It is recognized that key aspects of life experience and clinical change are not readily captured in research
using conventional clinical assessments that rely on self-report or episodic in-person exams. The desire to
capture this real-world data has been emphasized in the NIA and NACC developmental roadmap to integrate
digitally acquired measures (“digital biomarkers”) into the rich data currently included in the ADRCs databases.
The Oregon ADRC (OADRC) recognized the power of these emerging technologies, built on a decades-long
development of a digital platform through the Oregon Center for Aging & Technology (ORCATECH,
established 2004), its Roybal sister center (ORCASTRAIT), and leveraged the NIH-VA Collaborative Aging
Research using Technology (CART) initiative to, in 2019, establish the first Digital Technology Core (DTC)
within an ADRC to bring this new real-world data to the ADRC research community. To achieve the goal of
providing objective, real-world data, the DTC has established a readily deployable, home-based, unobtrusive,
and sharable system for capturing the desired continuous measurements of key features through digital
assessments of function (DAF), generating what are often called “digital biomarkers” known to change with
progression of ADRD. These include read-outs in known physiological drivers of ADRD such as sleep/activity
and BMI, the ability to use common devices (e.g., smartphones and computers, vehicles, pill boxes), in
physical function (e.g., gait speed, life-space movements), as well as in social interactions (e.g., out of home
activity, texting). Although these are of great interest in the transition from prodromal disease, this capability
has also found important application in other areas of dementia assessment beyond early detection such as
gaining insight into caregiver activity at home as well as agitation and sundowning behaviors in advanced
dementia. The use of these technologies is not limited to assessment, but also can deliver interventions such
as in dementia care programs via direct to home video appointments or social engagement through daily video
chats among isolated patients with MCI. Data collection is performed remotely on an individual home level as
opposed to in a clinic, thus lowering barriers and allowing more participants to engage in research, particularly
relevant to our Center’s focus on under-represented groups including the oldest old, Black, and isolated older
adults (e.g., those living alone or in rural communities). This proposal will consolidate and build upon recent
advances through the OADRC Digital Technology Core (DTC). Specific Aims are:
1. To maintain and make available for research, an OADRC dementia-specific focused Life Laboratory
cohort of research volunteers (healthy controls, MCI, and those with AD) who will have deployed in their
homes state-of-the-art sensing and pervasive computing platforms.
2. To obtain and make available for research DAF and related data on OADRC participants.
3. To foster collaborative research involving digital assessment, interventions, and related technologies.